A Precision Medicine Approach to Target Engagement for Emotion Regulation

Emotion dysregulation is a transdiagnostic maintenance factor involved in a wide array of costly and
debilitating psychiatric disorders. Although numerous full-model behavioral health treatments have been
designed to improve patients’ emotion regulation capacities, these treatments consist of multiple components,
making it difficult to discern which are active mechanisms leading to reductions in negative emotion intensity.
Further, it is unclear whether the delivery of these evidence-based components can be tailored to the individual
patient. The proposed Mentored Patient-Oriented Research Career Development Award (K23) is a four-year
plan to support the applicant’s long-term career goal of becoming a clinical scientist with expertise in (1)
identifying active mechanisms of emotion regulation interventions for psychopathology, (2) tailoring these
interventions to individual patients, and (3) developing scalable interventions for wide dissemination. The
applicant’s training and career thus far are aligned with these long-term goals. Throughout his graduate work,
he conducted studies testing emotion regulation mechanisms in transdiagnostic samples and used this
information to explore for whom these mechanisms were most impactful. The immediate goals of the K23
award are for the applicant to become skilled at intensive longitudinal experimental designs to disaggregate
between- from within-person mechanisms of change and enhance his proficiency in conducting and analyzing
multimethod assessments of emotion regulation. This proposal uses a two-phase approach to address these
goals. In line with an experimental therapeutics approach, the goal of Phase 1 is to compare the effects of
teaching one or three emotion regulation skills on daily changes in negative emotion intensity among
participants with elevated emotion dysregulation. The first goal of Phase 2 is to apply a personalization
algorithm based on Phase 1 data to an independent sample to determine which baseline participant
characteristics predict greater reductions in negative emotion intensity in each experimental condition. The
second goal of Phase 2 is to compare the effects of teaching participants emotion regulation skill(s) according
to their optimal or non-optimal delivery condition, based on the personalization algorithm. The training plan
closely matches the proposed research and long-term goals, including (a) developing advanced understanding
in statistical methods to test between- and within-person mechanisms of emotion regulation interventions, (b)
gaining proficiency in applying novel personalization algorithms, and (c) enhancing expertise in the
implementation and analysis of multimethod assessments of emotion regulation skills. The broader aim of this
research and training is to address the need for more efficient, personalized, and scalable interventions for
transdiagnostic psychiatric conditions, in line with the NIMH strategic plan. This study will answer important
theoretical and practical questions about the efficacy of different emotion regulation mechanisms on clinical
outcomes that may promote the development of more targeted and disseminable interventions.

Public health relevance
The proposed study is designed to first test whether teaching people with emotion dysregulation a single emotion regulation skill in depth or multiple emotion regulation skills in less depth leads to greater decreases in daily negative emotion intensity. Second, using data from an initial sample, we will prospectively assign an independent sample of participants to receive their predicted optimal or non-optimal skill condition to determine if it is feasible and efficacious to match the participants to a single- or multiple-skill condition. Results of these studies may identify the mechanisms by which emotion regulation interventions impact emotional functioning and allow for the development of personalized, evidence-based, and scalable emotion regulation interventions.